2/4 Powering Genetic Discovery for Severe Mental Illness in Latin American and African Ancestries

PROJECT SUMMARY
This project actualizes a primary goal of the Ancestral Populations Network (APN; PAR-20-026 and PAR-20-
027), namely to facilitate measurement and data analytic harmonization efforts across APN members to enhance
rigor and reproducibility and generate a resource for network members and the scientific community. Through a
consensus process of APN members, measures of anhedonia, cognition, obsessive-compulsive symptoms,
suicidality, and discrimination/stigma were selected for harmonization across ongoing studies. These
harmonized measures will be collected across an estimated 27,500 individuals representing Asian, Latin
American, and African ancestries spanning over 15 countries.

Public health relevance
PROJECT NARRATIVE The Phenotypic Harmonization Working Group of the Ancestral Populations Network (APN; PAR-20-026 and PAR-20-027) aims to facilitate measurement and data analytic harmonization efforts across APN members to enhance rigor and reproducibility and generate a resource for network members and the scientific community. This administrative supplement will allow APN members to collect harmonizable measures on four heritable, disease-related phenotypes from 27,500 individuals across diverse ancestries and environments.